KAPOSI'S SARCOMA AND SEXUALLY TRANSMITTED DISEASES

The causes of Kaposi's sarcoma are unknown. In the early 1980's the prevalence of this sarcoma among persons with AIDS was over 40 percent. In recent years, the prevalence has declined to under 20 percent in such individuals. This decline has paralled a similar decline in STDs in homosexually active men. Despite this decline, homosexually active men with AIDS continue to be 10 times more likely to develop Kaposi's sarcoma than injection drug users, transfusion recipients, and hemophiliacs with AIDS. Risk appears to be particularly elevated in homosexually active men who have a high number of sexual partners and who engage in oral-anal sexual behaviors. These observations suggest that a sexually transmitted agent may be involved in the etiology of Kaposi's sarcoma. The main goal of this project is to determine whether specific sexually transmitted and enteric infections play a role in the development of Kaposi's sarcoma. To address this goal, we propose to conduct a population-based cohort study. The cohort will consist of all residents of 13 counties in Western Washington State with newly diagnosed AIDS reported to the Washington State AIDS Reporting System from 1982 to 1992. Individuals in the cohort will be classified as having had syphilis, other sexually transmitted diseases, and selected enteric infections by computerized matching of the individuals in the cohort with existing state communicable disease databases. These data are based on reports of laboratory-confirmed diagnoses. Persons in the cohort with Kaposi's sarcoma, either at the time of their AIDS diagnosis (prevalent cases), or subsequently diagnosed (incident cases), will be identified by matching the cohort with the Cancer Surveillance System, a population-based cancer registry that covers 13 counties of Western Washington. Logistic regression and other analyses will be performed to estimate prevalence and incidence ratios of Kaposi's sarcoma in AIDS patients with syphilis and other sexually transmitted and enteric diseases relative to those without each of these conditions, respectively. Results from this study will provide further insights into the possible role of sexually transmitted and enteric agents in the etiology of Kaposi's sarcoma and may provide important clues as to how this disease can be prevented.